Tobacco Regulatory Science Investigating the Intersections of Products with Diverse Populations

ABSTRACT: Overall
Tobacco products are increasingly diverse. Non-cigarette products now garner a large market share; their use
and health impact varies across populations. Youth and young adult non-users of tobacco products are vulner-
able to initiation of e-cigarettes—a product posing risks both of nicotine dependence and of combustible tobacco
uptake. Yet, middle-aged/older adults may switch from combustible to e-cigarette products with potential health
benefits. The FDA is required to consider how regulatory policy has differing impact across subgroups to ensure
protection of the ‘population as a whole.’ Research addressing population diversity is scant. Through its theme,
the Intersections of Products with Populations, the University of Southern California Tobacco Center of Regula-
tory Science (USC-TCORS) will conduct research on the use and health effects of specific e-cigarette products
across populations. We will study e-cigarette product characteristics and marketing approaches hypothesized to
increase tobacco product attraction, use, and addiction in youth and young adult non-smokers and have little
impact on tobacco product use in older smokers. These e-cigarette products include: (a) non-tobacco flavorings;
(b) constituents and devices that produce large vapor clouds; (c) modifiable devices; (d) device designs not
resembling cigarettes; (e) cartoons in packaging and advertising; (f) candy flavors or other youth-oriented mar-
keting themes. Product standards and marketing requirements limiting non-combustible products with these
features to protect young people, while minimizing collateral effects on switching in adult smokers, would satisfy
FDA’s mission to protect the overall population. We will provide evidence to forecast whether such requirements
would have equitable impact across vulnerable groups defined by ethnicity, socioeconomic status, and sex that
are affected by widening tobacco disparities. Four complementary research projects employing differing meth-
odologies will test shared hypotheses on variation of the impact of e-cigarette product diversity on tobacco prod-
uct use by age, combustible tobacco use, and sociodemographic diversity: (1) characterization of publicly avail-
able social media postings of e-cigarette product characteristics and marketing themes that will be linked pro-
spectively with tobacco product use behavior in youth and young adults, (2) intercept interviews with customers
at vape shops to assess the impact of scenarios of e-cigarette regulation on tobacco product use, (3) cohort
studies of associations of e-cigarette product characteristics and marketing exposures with tobacco product use
and dependence across 10 years of early life, (4) laboratory tests of the impact of e-cigarette product character-
istics and marketing exposure manipulations on product appeal, abuse liability, and other outcomes. Supported
by a Center-wide scientific and career development infrastructure, USC-TCORS will provide the FDA with a
robust body of evidence to assess how various regulatory approaches to e-cigarettes are likely to affect the
health of vulnerable groups and the whole population. Scientific Domains: Addiction, Behavior, and Marketing.

Public health relevance
Narrative: There are many different types of products in the marketplace, including e-cigarettes of varying design and combustible cigarettes. This center’s research will study how these different products affect different groups in the population that are vulnerable to their use, such as adolescents. The goal is to help the Food and Drug Administration in protecting the health of vulnerable populations and to not limit use of e-cigarettes by cigarettes smokers who may benefit from switching to other tobacco products.